Multiple Sclerosis Lesion Magnetic Susceptibility Activity

? DESCRIPTION (provided by applicant): The long term objective of this project is to improve the capability to monitor the inflammatory and neurodegenerative processes in Multiple Sclerosis (MS) for effective diagnosis and treatment. The specific goal of this research is to establish the time course of magnetic susceptibility of lesions as a sensitive probe of demyelination and iron content associated with inflammatory processes. Currently, gadolinium enhancement in conventional magnetic resonance imaging (MRI) is widely used to map inflammation caused by blood brain barrier (BBB) disruption during MS lesion formation. However, there is still inflammation in the brain after the BBB heals and currently there is no method in clinical practice to detect this inflammation behind the BBB. Our preliminary data demonstrates that the time course of lesion magnetic susceptibility as measured by quantitative susceptibility mapping (QSM) can detect lesion activity after the resolution of gadolinium enhancement. Accordingly, this proposed research will try to establish the existence of and gain a basic understanding of the time course of MS lesion susceptibility by carrying out three specific aims: Aim 1: Improve QSM scanning robustness and processing accuracy for reliable longitudinal measurement of susceptibility time course. We hypothesize that QSM can be improved to high reproducibility and accuracy of 0.01ppm (parts per million, susceptibility unit). Aim 2: Define the MS lesion magnetic susceptibility time course through prospective longitudinal study of the susceptibility of lesions at all ages, with spatiotemporal correlation of gadolinium enhancement measured by conventional MRI. We hypothesize that lesion susceptibility changes dynamically over time, even after inflammatory activity, as measured by conventional MRI, has subsided. Aim 3: Define the immunohistochemical correlates of MS lesion magnetic susceptibility using autopsied brain specimens from MS patients and controls. We hypothesize that the QSM signal of an MS lesion correlates in part with microglia/macrophages activation (i.e. inflammatory activity) and that the QSM value of a fully demyelinated lesion is determined by iron.

Public health relevance
PUBLIC HEALTH RELEVANCE: The long term objective of this proposed research is to improve the management of Multiple Sclerosis (MS) patients by advancing our capability of probing the inflammatory and neurodegenerative processes in MS through the development of a noninvasive Quantitative Susceptibility Mapping (QSM) technique in MRI. The time course of MS lesion magnetic susceptibility is a promising biomarker for demyelination in inflammation and iron distribution in both inflammation and neurodegeneration. This research project will focus on establishing the lesion susceptibility time course using a longitudinal prospective study. This research will provide biomedical correlates using immunohistochemical analysis of MS brain specimens, in addition to gadolinium enhancement in longitudinal patient study. Successful outcome of this research will establish that QSM time course of MS is a valuable tool for monitoring the pathogenic process of MS for effective diagnosis and treatment of the more than two million MS patients worldwide.